PHARMACOKINETICS AND SAFETY OF LOBUCAVIR IN SUBJECTS WITH HEPATIC IMPAIRMENT

Accomplishments: To date we have enrolled 6 volunteers in the protocol with no significant adverse events. Analysis of data is pending study completion.